Analysis of conserved eukaryotic transcription elongation factors

PROJECT SUMMARY/ABSTRACT
The long-term objectives of this project are to increase our understanding of eukaryotic transcription
elongation, with a focus on histone chaperones. Histone chaperones control the assembly and disassembly of
nucleosomes during transcription, replication, and repair. The proposed experiments address the conserved
histone chaperone Spt6, using the yeast Saccharomyces cerevisiae, as a model system. Spt6 is conserved
and its human counterpart has been implicated in developmental control and in cancer. Previous analysis of
Spt6 has demonstrated that it is broadly required for transcription and chromatin structure in both yeast and
mammalian cells. While it is established that Spt6 interacts with histones, RNA polymerase II, and other
proteins, the mechanisms by which it functions are unknown. The proposed experiments in Specific Aim 1 will
address the interactions of Spt6 with two other essential and conserved histone chaperones, Spn1/Iws1 and
FACT. Preliminary studies have shown that an spt6 mutant, spt6-YW, that impairs the physical interaction of
Spt6 with Spn1, has changes in growth, transcription and chromatin structure. Additional studies identified
suppressor mutations that compensate for spt6-YW mutant defects. Several of these suppressor mutations
cause clustered changes in a conserved surface of FACT. Aim 1.1 tests the model that spt6-YW and its
suppressors control transcription and chromatin structure via alterations of the transcription elongation complex
and histone modifications. This will be assayed by a set of ChIP-seq experiments. Aim 1.2 studies the
changes in FACT that compensate for the Spt6 defect. These results will provide new understanding of the
functional relationships among histone chaperones and provide insights into why so many of them are vital
during transcription. Specific Aim 2 focuses on Spt6 binding to histones, an essential function for all of histone
chaperones. This aim tests the model that Spt6 has multiple histone binding sites in its highly acidic and
disordered N-terminal domain. Aim 2.1 will isolate spt6 mutants in the N-terminal region that are defective for
function. Aim 2.2 will use these mutants to define Spt6-histone binding in vitro. Aim 2.3 will address key issues
regarding Spt6-histone interactions during transcription. Together, these experiments will elucidate an
essential function of Spt6. Specific Aim 3 addresses a related but distinct role for Spt6, in the control of
genome integrity, as spt6 mutants display genome instability phenotypes. The proposed experiments will test
whether Spt6 is required for genome stability by the control of chromatin structure, transcription, or resolving
transcription-replication conflicts. Experiments will assay RNA:DNA hybrids, which contribute to genome
instability, double-strand DNA breaks, and will test the model that Spt6 is required for DNA replication as well
as transcription. The results will provide new understanding of the control of genome stability, a fundamental
and conserved process important for human health.

Public health relevance
PROJECT NARRATIVE All organisms must regulate the expression of their genetic information for normal growth and development. This application proposes to study this regulation by the analysis of proteins that are essential for normal gene expression. The information learned from these studies will improve our understanding of human biology.